Clinically Translatable MRI Reporter Genes and Imaging Methods with Ultra-High Specificity and Sensitivity

PROJECT SUMMARY
Magnetic resonance (MR) reporter genes have the potential to monitor transgene expression non-
invasively in real time at high resolution. These genes can be applied to interrogate the efficacy of gene
therapy, monitor oncolytic virotherapy, and assess cellular differentiation, cell trafficking, and specific metabolic
activity. Despite initial efforts toward developing MRI reporter genes, there are numerous complications,
caused by the low sensitivity and specificity of detection, the requirement for substrates with undesirable
pharmacokinetics, and the difficult interpretation of often delayed signal changes.
We have previously demonstrated that many of these challenges can be overcome with the use of a lysine
rich protein (LRP) reporter gene, that is detectable by chemical exchange saturation transfer (CEST) MRI, in
which a frequency-selective radio-frequency pulse is used to saturate the amide exchangeable proton signal of
the protein reporter. Our previous research efforts (supported by R01-EB031008) were focused on optimizing
the amide proton-based reporter gene stability, maximizing the reporter protein expression, and optimizing the
detection sensitivity by maximizing the amide proton exchange rate (kex). While we succeeded on all three
counts, we found that the small chemical shift dispersion (Dw) of amide protons ultimately limits the sensitivity
and specificity, while the very high RF powers required to efficiently saturate these fast-exchanging amide
protons limits the clinical translation potential.
Taking the reporter gene technology to the next level will require both (1) designing reporter proteins with
exchangeable protons with significantly increased Dw, allowing for much higher specificity and sensitivity; and
(2) developing MRI methods for detecting fast exchanging protons that do not require high saturation powers
and can be implemented on clinical MRI scanners. In our previous research efforts to optimize amide-based
reporter proteins, we discovered peptides and proteins containing tyrosine (Tyr) and tryptophan (Trp) residues
that demonstrated CEST contrast from highly shifted (4-10 ppm) phenol OH and indole NH protons, with
optimal kex of 2000-6000 s-1. In addition, we discovered that a water resonant chemical exchange-sensitive
spin-lock (CESL) magnetic resonance fingerprinting (MRF) method can provide high detection sensitivity for
fast exchanging protons without requiring high RF powers, making it suitable for clinical translation.
We hypothesize that chemical exchange sensitive reporter proteins can be detected with ultra-high
sensitivity and specificity under clinically relevant conditions. To test this hypothesis, and establish the clinical
potential of MRI reporter genes, we will capitalize on two transformative technologies developed in our labs;
(Aim 1) the discovery of Tyr- and Trp-based reporters with large Dw and fast kex; (Aim 2) the development of a
CESL-MRF method for quantification of the reporter protein concentration and kex. Finally, the new reporter
genes and CESL-MRF will be tested for imaging oncolytic virotherapy in mouse tumor models (Aim 3).

Public health relevance
PROJECT NARRATIVE Cell and viral based therapies have the potential to revolutionize the treatment of many diseases. However, the optimization of such biological therapies depends critically on the ability to monitor the spread and persistence of the therapeutic agent and assess the tissue response. This project therefore proposes to develop and optimize a novel MRI reporter gene technology that allows for the imaging of cell and viral based therapeutics.